Genomic Analysis of Cutaneous CD30+ Lymphoproliferative Disorders

PROJECT SUMMARY/ABSTRACT
ALK-negative systemic anaplastic large cell lymphoma (sALCL) is an aggressive disease requiring intense
chemotherapy. The primary cutaneous CD30+ lymphoproliferative disorders (CD30+LPD) of lymphomatoid
papulosis (LyP) and primary cutaneous anaplastic large cell lymphoma (pcALCL) are indolent, less well
recognized entities. Distinguishing sALCL, LyP, and pcALCL histologically is difficult; this often leads to
misdiagnosis and overaggressive treatment of patients with CD30+ LPD. The 5-year survival rate is 92% for LyP
and 90% for pcALCL when managed with standard of care, non-targeted, skin-directed therapies. The 5-year
survival rate is 15-45% for ALK-negative sALCL and requires aggressive treatment with potentially fatal side-
effects. Thus, there is a critical clinical need to differentiate the LyP and pcALCL CD30+ LPD from ALK-
negative sALCL since each has distinct prognoses and requires different treatment plans.
In the era of personalized medicine, physicians and scientists are looking to characterize tumors molecularly
with the goal of developing markers for diagnosis and directing therapy at the underlying mutation(s). Molecular
characterization is incomplete for CD30+ LPD. The clinical application of whole genome sequencing (WGS),
whole exome sequencing (WES) and RNA sequencing (RNA-seq) will help differentiate among these entities.
Through upstream analysis of genomic variability and pathway changes by WGS and WES integrated with RNA-
seq to identify expressed mutations, we anticipate that completion of the proposed research will yield molecular
signatures of LyP, pcALCL, and sALCL. This will change the current paradigm of relying solely on clinical
pathologic correlation by a few experts at large academic centers, which delays achievement of the correct
diagnosis beyond the point of treatment selection. However, a significant barrier is obtaining a statistically
significant number of specimens to complete a meaningful analysis, since CD30+ LPD are rare entities. To
overcome this obstacle, City of Hope has already established a consortium of five tertiary referral centers to
contribute not only tissue but also clinical information. The consortium is unique in that it leverages multiple
experienced investigators in the clinical, pathologic, and translational areas of lymphoma research who analyze
the largest group of specimens to date. By facilitating more accurate diagnosis of LyP and pcALCL, the proposed
studies will potentially help prevent over-treatment of patients with CD30+ LPD with chemotherapy, thus
eliminating the unnecessary side-effects of chemotherapy, including shortened overall survival due to treatment.

Public health relevance
PROJECT NARRATIVE Systemic or nodal anaplastic large cell lymphoma (sALCL) that is ALK-negative is an aggressive lymphoma with a histology and immunohistochemical profile nearly identical to those of less well-known indolent primary cutaneous CD30+ lymphoproliferative disorders (CD30+ LPD). This overlap often this leads to misdiagnosis and unnecessary overaggressive chemotherapeutic treatment of patients with lymphomatoid papulosis (LyP) and primary cutaneous anaplastic large cell lymphoma (pcALCL). Our overarching objective is to molecularly characterize the CD30+ LPD, so that genetic information can be used to more accurately diagnose LyP and pcALCL, thereby preventing the over-treatment of patients with CD30+ LPD and eliminating unnecessary side-effects of chemotherapy, including shortened overall survival due to treatment.